A framework for integrating MR imaging and clinical tests for prediction of outcomes in multiple myeloma treatment

Abstract
Multiple myeloma (MM) is the second most common hematologic malignancy (after non-Hodgkin lymphoma)
in the U.S. Over the past decade, despite the advent of novel therapies that has improved the life expectancy of
patients with MM, MM is still incurable. Patient outcome varies widely with overall survival (OS) ranging from
less than 1 year to greater than 10 years. The large variability of patient overall survival resulting from the high
heterogeneous microenvironment of MM heightens the needs of risk-adapted treatment for long-term control,
which are largely relied on accurate assessment of tumor evolution and survival prediction. The International
Myeloma Working Group (IMWG) guideline and several other different prognostic models have been used to
assess treatment outcomes. These systems utilize different subsets of laboratory values from clinic tests as
assessment criteria, which may not indicate the full extent of tumor burden. MRI is the gold standard imaging
modality for detection of bone marrow involvement. It provides global representation of the tumor burden, even
for patient with non-secretory or hypo-secretory MM. We hypothesize that integrating multimodal information
delivered by time serial noninvasive MR imaging and clinical tests will provide more robust and accurate
modeling of MM evolution during and after treatment, and thus can predict treatment outcomes more reliably at
an early time. Our goal is to develop a framework of decision support system (DSS) that integrates MR images
and clinical tests to assist physicians in making informed decisions on tailoring treatment for an individual MM
patient. The proposed study aims to (1) Investigate the effectiveness of MRI radiomic features in characterizing
MM infiltration and their correlations with treatment outcomes, (2) Investigate the circumstances how the
combination of MRI radiomics and clinical tests complements each other and is more powerful in early prediction
of treatment outcomes. To achieve these aims, we will retrospectively collect a large data set of MM cases with
baseline and follow-up MRI scans and clinical tests for development and validation of the DSS system. We will
utilize advanced artificial intelligence (AI) techniques including recurrent neural networks and reinforcement
learning to train predictive models with time serial MRI and clinical data acquired at multiple time points, which
allows the trained models to be deployed flexibly to each individual time point for treatment assessment to
facilitate early prediction. Furthermore, these advanced AI techniques can learn intertemporal dependencies
from available data to compensate for the missing data or exams at single time points in serial exams which may
occur in real-world clinical situation. With a flexible modular architecture design of our DSS system, we will
investigate the inter- and intra-relationships between MRI and laboratory variables for better understanding of
their complementarity in characterizing tumor burden during MM treatment and their association with treatment
outcomes. As a final step, using an independent multi-institutional test set, we will validate the performance of
the developed DSS in predicting the recurrence risk at an early time point during treatment.

Public health relevance
Narrative: MM is a common disease that can cause substantial morbidity and mortality in patients. The success of the predictive models developed in this project will not only provide a quantitative and reliable decision support for early prediction of treatment response and patient outcome but also constitute a strong foundation to meet our long-term goal of developing a clinically-translatable framework to facilitate clinical decision making in early diagnosis and tumor burden assessment, staging, assessing treatment response, optimizing therapeutic regimens, monitoring MM progression/regression and detecting recurrence, as well as assisting in new therapeutic agent and drug development. The advancement in these areas is expected to deliver the promise of precision medicine for MM by improving patient outcomes and reducing the cost of healthcare.